Daily Experience in Adolescence and Biomarkers of Early Risk for Adult Health

DESCRIPTION (provided by applicant): Despite calls for the identification of early risk factors for the development of chronic health conditions, there has been little longitudinal research on biomarkers of health that has been conducted in persons younger than 25 years of age. In addition, there is only a minimal understanding of how biological indices of early risk for adult health develop among adolescents with Latin American and Asian backgrounds, the two fastest rising ethnic groups in the United States, who are at differential risk for adverse health outcomes as compared to European Americans. An understanding of these processes is necessary for the development of ethnically and culturally relevant prevention efforts. We propose a 3-wave longitudinal study of adolescents and their caregivers from Mexican, Chinese and European backgrounds in order to assess the impact of daily experience on biological indicators of early risk for adult health. Our focus on daily experience stems from the need to identify the mechanisms by which global social factors identified in demographic surveys, such as lower education and income, play themselves out in individuals' daily lives. Daily experiences such as social conflict, excessive demands, emotional distress, threat, and sleep behaviors have been shown to be linked to both global risk factors and multiple biological indices of health risk among adults. The project will include both intensive behavioral assessments and detailed biological markers of health risk from both adolescents and their parents in order to address the following specific aims: (1) describe the development during adolescence of biological indices of early risk for adult health; (2) assess the role of daily experience in the development of early health risk; (3) examine the existence of ethnic disparities in early health risk; and (4) explore the role of potential protective factors in the development of early health risk. Approximately 540 pairs of adolescents and primary caregivers (180 from each ethnic group) will be assessed when the adolescents are approximately 15-16, 17-18, and 19-20 years of age. Each year, both adolescents and caregivers will participate in interviews that include measures of global social factors such as socioeconomic background and potential protective factors such as social connectedness. Participants will report daily experiences using a nightly diary checklist for 9 consecutive days. Salivary cortisol will be obtained at 4 time points each day for 4 of these days in order to analyze HPA activity, and participants will wear wrist actigraphs for the same 4 days to measure objective sleep behaviors. Blood pressure, BMI, and waist/hip ratio will be assessed, and dried blood spots will be obtained for the assessment of c-reactive-protein (CRP), cholesterol, and high density lipoproteins (HDL). Finally, peripheral blood samples will be provided by a subsample of 120 families for the assessment of plasma interleukin-6 (IL-6), a pro-inflammatory cytokine, and for gene expression analyses of molecular signaling pathways driving inflammatory biology.

Public health relevance
PUBLIC HEALTH RELEVANCE: There is only a minimal understanding of how biological indices of early risk for adult health develop among adolescents with Latin American and Asian backgrounds, the two fastest rising ethnic groups in the United States, who are at differential risk for adverse health outcomes as compared to European American. More in-depth examinations of the daily lives of adolescents from these populations could identify both the sources of these disparities as well as unique risk and protective factors. An understanding of these processes is necessary for the development of ethnically and culturally relevant prevention efforts. Project Narrative There is only a minimal understanding of how biological indices of early risk for adult health develop among adolescents with Latin American and Asian backgrounds, the two fastest rising ethnic groups in the United States, who are at differential risk for adverse health outcomes as compared to European American. More in-depth examinations of the daily lives of adolescents from these populations could identify both the sources of these disparities as well as unique risk and protective factors. An understanding of these processes is necessary for the development of ethnically and culturally relevant prevention efforts. __SpecificAimsTextDelimiter__ 2. SPECIFIC AIMS Despite calls for the identification of early risk factors for the development of chronic health conditions, there has been little longitudinal research on biomarkers of health that has been conducted in persons younger than 25 years of age. In addition, there is only a minimal understanding of how biological indices of early risk for adult health develop among adolescents with Latin American and Asian backgrounds, the two fastest rising ethnic groups in the United States. Recent studies during mid-life have suggested that Latinos have higher levels of several chronic health conditions, such as obesity, cardiovascular disease (CVD), and type 2 diabetes mellitus as compared to European Americans. Asians, in contrast, appear to have fewer such health problems. More in-depth examinations of the daily lives of these populations could address both the sources of these disparities as well as unique risk and protective factors. We propose a 3-wave longitudinal study of adolescents and their biological parents from Mexican, Chinese and European backgrounds in order to assess the impact of daily experience on biological indicators of early risk for adult health. Our focus on daily experience stems from the need to identify the mechanisms by which global social factors identified in demographic surveys, such as lower education and income, play themselves out in individuals' daily lives. Daily experiences such as social conflict, excessive demands, emotional distress, perceived threat, sleep, and health behaviors have been shown to be linked to both global risk factors and multiple biological indices of health risk. These key daily experiences offer promising points of intervention to minimize the impact of less malleable global risk factors such as lower education and income. The project will include both intensive behavioral assessments and detailed biological markers of health risk from both adolescents and their parents in order to address the following specific aims: Aim 1. Describe the development during adolescence of biological indices of early risk for adult health. Little longitudinal data exist on how biological correlates of health risk develop before adulthood. We will collect three waves of data on multiple biological indicators of health risk during adolescence, including hypothalamic- pituitary-adrenal (HPA) activity, inflammation (c-reactive protein, interleukin-6, expression of inflammation- related genes), cholesterol and blood pressure, body mass index (BMI), and waist/hip ratio (WHR). A particularly unique aspect of the project will be the inclusion of gene expression analyses that enable the identification of molecular signaling pathways that underlie inflammatory biology. Aim 2. Assess the role of daily experience in the development of early health risk. Much of our existing knowledge of the role of social factors on risk for chronic health conditions is based upon surveys of global factors such as income and education, with little knowledge about how they create health risk. In addition to assessing global social factors, we will obtain detailed measures of daily stressors, emotion, and sleep that will allow us to better understand the mechanisms by which social factors produce early health risk. Daily health behaviors such as physical activity, smoking, drinking, medication, and use of other substances also will be assessed. Aim 3. Examine the existence of ethnic disparities in early health risk. Our project will sample individuals from Mexican, Chinese, and European American backgrounds in order to test whether the disparities in health risk observed during mid-life are evident during the adolescent years. Our detailed assessment of both social conditions and daily experience will allow us to test for the sources of such disparities, as well as identify any risk factors that are unique to particular ethnic groups. Aim 4. Explore the role of potential protective factors in the development of early health risk. Less is known about factors that may minimize risk, and our project will focus on the role of three potential factors: social connectedness, a sense of meaning and purpose, and positive events and emotions. Approximately 540 pairs of adolescents and one of their biological parents (180 from each ethnic group) will be assessed when the adolescents are 15-16, 17-18, and 19-20 years of age. Each year, both adolescents and parents will participate in interviews that include measures of global social factors such as socioeconomic background and potential protective factors such as social connectedness. Participants will report daily experiences using a nightly diary checklist for 9 consecutive days. Salivary cortisol will be obtained at 4 time points each day for 4 of these days in order to analyze HPA activity, and participants will wear wrist actigraphs for the same 4 days to measure objective sleep behaviors. Blood pressure, BMI, and WHR will be assessed, and dried blood spots will be obtained for the assessment of c-reactive-protein (CRP), cholesterol, and high density lipoproteins (HDL). Finally, peripheral blood samples will be provided by a subsample of 120 families for the assessment of plasma interleukin-6 (IL-6), a pro-inflammatory cytokine, and for gene expression analyses of molecular signaling pathways driving inflammatory biology.